Program in Blood Coagulation and Vascular Biology

Project Summary/Abstract
The goal of this program is to train MD and PhD postdoctoral fellows in biomedical research as
it applies to Blood Coagulation and Vascular Biology. We offer a multi-disciplinary program that
consists of didactic instruction, seminars and supervised research. Important elements of the
curriculum are supervision by faculty advisors, formal course work, interactions between trainee
and the faculty, and interactions between the trainee and peers. Dr. Robert Flaumenhaft is the
Program Director and Drs. Bruce Furie and Kenneth Bauer are the Associate Program
Directors. Faculty of the program, largely members of the Department of Medicine at Beth Israel
Deaconess Medical Center and Harvard Medical School, share a scientific interest in blood
coagulation and vascular biology. MD trainees are selected from 350 to 425 applicants each
year. Only those applicants with an explicit commitment to a career in academic medicine are
selected. This training plan is integrated into the hematology training program. MD trainees
choose between two tracks. The Physician-Scientist Track consists of a minimum of two years
of supervised bench research and didactic instruction after completion of the major portion of
hospital-funded clinical subspecialty training. The Clinical Investigator Track prepares
participants for a career in clinical investigation in the areas of blood coagulation and vascular
biology. We also receive approximately 300 applications per year from candidates with a PhD
degree or physicians applying solely for research training. The design of the program takes into
account (a) the need for physicians to acquire knowledge of advances in molecular and cell
biology; (b) the need for an extended training experience to allow fellows to develop
sophistication in modern biomedical research; (c) the need for PhD scientists to understand the
pathobiology of the vascular system. This grant, funded for the past 18 years, is a continuation
of T32 HL07437, which had been active at Tufts Medical Center for 20 years. This training
program has proved exceptionally successful, with over 50% of our trainees obtaining Faculty
positions at academic centers, 38% pursuing careers in the biotechnology sector, 5% working in
alterative scientific academic roles (e.g., senior editor) and less than 5% in private practice. This
Program has produced leaders in the fields of blood coagulation and vascular biology and has
had important impact in sustaining basic research in the field of hemostasis and thrombosis.

Public health relevance
Project Narrative Research in hemostasis, thrombosis, and vascular biology addresses fundamental mechanisms underlying bleeding and thrombotic disorders, which as a group account for more than half of all morbity and mortality among U.S. citizens. This Program in Blood Coagulation and Vascular Biology will train the next generation of scientists to study problems related to hemostasis, thrombosis, and vascular biology.